The Role of TSH-beta Splice Variant in Health and Disease

PROJECT SUMMARY/ABSTRACT Although it has been known for over three decades that thyrotropin (thyroid stimulating hormone [TSH]) is produced by cells of the immune system, the physiologic significance of that remains unclear. Studies in our laboratory demonstrated that cells of the immune system produce a novel TSHβ splice variant (TSHβv), the first functional splice variant of TSHβ to be identified for mice and humans. Importantly, this is the sole form of TSHβ produced by the immune system. We demonstrated that TSHβv expression is increased in the thyroid of mice infected with reovirus or L. monocytogenes, due principally to the trafficking of TSHβv-producing cells to the thyroid during infection. Based on those and other studies, we propose that immune system TSHβv plays a key role in regulating host metabolic activity by modulating thyroid hormone synthesis. In this R21 grant, we will test the hypothesis that suppression of TSHβv expression in the cells of the immune system will cause dysregulated thyroid hormone synthesis, altered host metabolic activity, and disrupted bone morphogenesis in mice under normal healthy conditions, and in pathophysiologic settings during infection. There are two Specific Aims for the project. Aim 1 To assess the effects of TSHβv suppression on basal metabolism, thyroid hormone synthesis, and bone morphogenesis in normal mice. Aim 2. To assess the effects of TSHβv knockdown on basal metabolism, thyroid hormone synthesis, and bone morphogenesis during viral and bacterial infection. We will use two approaches to suppress TSHβv. In the first, shRNA-TSHβv lentivirus will be used to suppress TSHβv in bone marrow hematopoietic cells and peripheral leukocytes. In the second, we will knockout TSHβv in animals by Crispr/Cas9 gene editing. These studies will be the first to directly examine the functional involvement of immune system TSHβv during normal homeostatic conditions and during times of immunological stress. They are expected to greatly expand our knowledge of immune-endocrine interactions in ways not appreciated to the present.

Public health relevance
PROJECT NARRATIVE We have shown that bone marrow cells and splenic leukocytes produce a novel splice variant of the β- subunit of thyroid stimulating hormone (TSHβv), and that after trafficking to the thyroid, splenic leukocytes secrete TSHβv intrathyroidally. We have proposed that TSHv plays an essential role in regulating host metabolism by critically modulating thyroid hormone synthesis, and that it is also involved in bone morphogenesis. We will test this by selectively suppressing TSHv in cells of the immune system in normal mice and in mice during bacterial and viral infections. These studies will be the first to directly determine the effects of suppressed immune system TSHv in health and disease.